Task 4: The Interventional Agent Development Services program

This contract provides for preclinical microbiological, safety, toxicology and biokenetics services under the NIAID Preclinical Services for the Development of Interventional Agents Program.